Comparative Biomedical Research Training for Veterinarians

Project Summary/Abstract
The critical national shortage of veterinary scientists with PhD training who can provide their unique
expertise in biomedical research recognized. The National Institutes of Health (NIH) and National Research
Council have recognized that veterinarians are broadly trained health professionals who are uniquely qualified
to lead biomedical research, having an understanding of disease in the context of the whole organism. The
Texas A&M College of Veterinary Medicine (TAMU CVM) T32 training program is a three-year post-doctoral
training program with the objective of providing PhD training to veterinarians in cutting edge biomedical research
approaches and address the national need for this expertise. This renewal builds upon two previous successful
project periods, 2010-2014 and 2015-2020, under the directorship of Dr. Ann Kier, who will assume an Advisor
role to the PD (Albert Mulenga) and this renewal and serve on student committees. The TAMU CVM T32 will
recruit outstanding trainees DVMS. In previous budget periods, trainees were recruited after they had completed
their DVM residency program at the TAMU CVM or other schools in different specialties and had passed their
specialty boards. During the residency program, prospective trainees with expressed desire to join the T32
program are advised to take relevant coursework pertinent to the PhD training. In this way, trainees will focus on
conducting their dissertation research and complete PhD degree requirement within the three years that is
supported under T32 funding. In the event that the trainee does not meet requirement for PhD graduation during
the three-year T32 support, the mentor will provide support. During the two project periods, the program recruited
14 DVMs into graduate school. Of the 14 trainees, eight have graduated with their PhDs and seven have taken
employment in biomedical research, one is in a temporary private practice, one is on schedule to complete her
PhD, and five are still in training. Of the five; one trainee on track to finish in spring of 2020. Of the five, one
trainee is on track to finish in spring of 2020 and the remaining are scheduled to graduate during this renewal:
one trainee in year one of this renewal, and two in year two, and one in year 3.
The NIH has recognized the fact that although the veterinary curriculum is analogous to medical school
training, it provides an added benefit, the comparative nature of training in normal anatomy/physiology and
abnormal disease states, providing an excellent basis for biomedical disease inquiry. This specialized training
uniquely prepares veterinarian researchers to contribute to biomedical research in the modeling of human
pathophysiology using laboratory animal models. The NIH Roadmap for Medical Research is designed to open
up new opportunities to tackle the multifactorial causes of diseases not yet understood, particularly those
associated with a longer lived, aging population, including heart disease, obesity, diabetes mellitus,
autoimmunity, and increased susceptibility to infectious diseases. The comparative nature of their training equips
veterinarians with insight and expertise to conduct clinical research.

Public health relevance
The National Institutes of Health and National Research Council recognize that veterinarians are broadly trained health professionals who are uniquely qualified to lead biomedical research, having an understanding of disease in the context of the whole organism. Veterinary scientists play critical roles in combating disease and safeguarding public health. With this competitive training grant renewal proposal, we hope to help address the national shortage of these highly trained and valuable individuals.